Administrative Core A

Project Summary
The Administrative Core (Core A) is the principal management component of the Center
for Male Reproductive Epigenomics and thus, is critical to the success of the entire
Center. Core A will serve as an interface between the Center Project Leaders (PLs), Core
Directors, and the Internal (IAC) and External (EAC) Advisory Committees, as well as the
three participating institutions. Core A will provide administrative support for the three
projects and two technical core labs, as well as the Community Outreach and Education
core, including scheduling meetings, coordination of the usage of existing core facilities,
managing the budget, helping seminar speakers with their travel and itinerary, depositing
data for sharing, facilitating recruitment activities, dealing with public relations, etc. Core
A will also maintain the Center’s website that will serve as a window to the public and
information source for other NCTRI programs around the nation by displaying relevant
information about the Center, including announcements of Center meetings, seminars,
workshops, event calendar, noteworthy news, research highlights, publications of Center
participants, etc. To accomplish these administrative functions, we will provide centralized
administrative and scientific support and oversight to all projects and cores (Aim1),
communicate with both the Internal Advisory Committee (IAC) and the External Advisory
Committee (EAC) and coordinate the IAC and EAC meetings to enhance the performance
of the Center (Aim2), provide financial and managerial support to ensure the Center’s
financial health and to minimize the managerial burden of Project Leaders and Core
Directors (Aim3), and assist the Internal Advisory Committee in resolving issues of conflict
of interest, financial disputes or other matters that are not resolved by the Executive
Committee (Aim 4).

Public health relevance
Project Narrative The administrative core (Core A) will provide administrative supports to all research projects and core labs in the Center for Male Reproductive Epigenomics, a premier research program with a thematic focus on studying both the impact of life style or environmental (diet/activity) factors on the integrity of the sperm epigenome, and the key molecular mechanisms underlying sperm-mediated epigenetic inheritance of disease.